Mitochondria, Metabolism and Heart

ABSTRACT Support is requested for a Keystone Symposia conference entitled Mitochondria, Metabolism and Heart organized by Drs. Elizabeth Murphy and Zoltan P. Arany. The conference will be held in Santa Fe, New Mexico from January 14-18, 2021. It is well known that mitochondria are the powerhouse of the cell and are responsible for generating ATP via oxidative metabolism and electron transport. Mitochondrial transporters regulate mitochondrial calcium levels which in turn are important in regulating cell metabolism and death. However, alterations in mitochondrial function and metabolism have been shown to be important regulators of cardiovascular disease such as heart failure. Despite the importance of mitochondria in health and disease, the identity of many ion transporters is still unknown. In particular, the identity of the mitochondrial permeability pore that regulates cell death is still debated. In addition, the links between mitochondrial dynamics and mitochondrial metabolism and cell death are poorly understood. Therefore, this conference will emphasize experts using novel approaches such as high-resolution imaging techniques, metabolomics, proteomics and systems biology to elucidate mechanisms by which mitochondrial transporters and mitochondrial dynamics regulate metabolism, death and disease. Finally, this conference is being paired with a Keystone Symposium on Heart Failure: Mechanisms and Therapies. This pairing will include two joint sessions will focus on mitochondrial function and metabolism, respectively.

Public health relevance
PROJECT NARRATIVE Mitochondria are the powerhouse of the cell and are responsible for generating ATP via oxidative metabolism and electron transport. However, alterations in mitochondrial function and metabolism have been shown to be important regulators of cardiovascular disease such as heart failure (HF). In the United States alone, the prevalence of HF continues to rise yet the prognosis for patients with HF remains disappointingly poor. Therefore, this conference brings researchers working in the HF field together to advance scientific understanding of the mechanism by which mitochondrial and metabolic reprogramming contribute to cardiac dysfunction and heart failure.